Modulation and functional characterization of protein condensation in chromatin organization

Project Summary
Recent discoveries of the phase-separation abilities of several chromatin regulators have led to novel models
for chromatin organization. Directly testing the causal effects of phase-separation mechanisms requires an ability
to quantitatively tune the phase-separation ability of an endogenous chromatin regulator and simultaneously test
for gene expression and cell fate changes. For this goal, we will develop two tool kits: (1) a phase-dial to enhance
or suppress the phase-separation potential of endogenous proteins in a quantitative and controlled manner, and
(2) a robust and transferrable technological platform to correlate live imaging of phase condensates with the
profiling of gene expression at the single cell level. Utilizing these tools, we will study the regulation and impact
of heterochromatin formation and transcription activation during stem cell differentiation.

Public health relevance
Project Narrative Recent discoveries of the phase-separation abilities of several chromatin regulators have led to novel models for chromatin organization. This project aims to develop biochemical, genetic and computational tools that enables studying the functional role of chromatin regulator phase-separation in individual living cells. We will apply these tools to the study of the regulation and impact of heterochromatin formation and transcription activation during stem cell differentiation.